Cultural Adaptation of Family Check-Up to Reduce Health Disparities and Improve MentalHealth among Hispanic Families

PROJECT SUMMARY
Mental health problems have increased substantially in the last decade, and Hispanic youths’ experiences of
racism and marginalization increases risk for internalizing and externalizing symptoms. Effective
implementation of evidence-based interventions is critical to reduce mental health disparities among ethnic
minority populations and to scale up for dissemination. Cultural adaptation has improved parenting practices
and youth outcomes beyond the original evidence-based parenting interventions and has the potential to
support cultural socialization, which is associated with mental health among Hispanic youth. We have
developed Family Check-Up Online (FCU Online), a mobile, web-based application designed to reduce
internalizing and externalizing behaviors (e.g., depression, anxiety, child problem behavior). The goals of this
Phase 1 study are to culturally adapt the FCU Online for Hispanic parents and to test the feasibility,
acceptability, and commercial potential of the adapted intervention. A community engaged approach will be
employed to identify strategies to improve access to and uptake of the intervention, leveraging community and
cultural resiliency-promoting assets. Promotores de salud, Spanish-speaking community health workers will
provide feedback and pilot delivery the program to meet the needs of Latinx families from diverse
backgrounds. To reach the goals of the study, the following aims will guide this research. In Aim 1, interviews
with parents and community leaders, including promotores de salud, will inform the ecological, cultural
adaptation of the FCU Online modules and the online portal for promotores de salud. In Aim 2, the online
version of the intervention will be adapted using iterative Plan-Do-Study-Act cycles to get usability feedback
from parents and promotores de salud, consistent with best practices designed to adapt interventions in
community settings. In Aim 3, using mixed methods, researchers will assess feasibility, accessibility, and
commercial potential of the adapted FCU Online. The team will recruit 10 Hispanic families and 5 promotores
de salud to participate in a pilot trial. Feasibility and accessibility will be assessed according to quantitative
benchmarks, including technology usage data, a telehealth usability survey, and a consumer satisfaction scale.
Qualitative feedback will assess the barriers and facilitators of using the adapted FCU Online. Qualitative and
quantitative data will be integrated for analysis. Findings from this study will inform a future Phase 2
randomized controlled trial to test effectiveness in a real world setting to scale up dissemination of the adapted
FCU Online among Spanish speakers. This research has potential to reduce lifetime risk for depression,
anxiety, and externalizing behaviors among Hispanic youth by improving parenting practices and supporting
cultural socialization.

Public health relevance
Project Narrative In this study, we propose to culturally adapt the online version of Family Check-Up and identify strategies to reduce barriers to engagement and support effectiveness using a community-engaged approach. We will use a mixed-methods approach to guide adaptation of the online model through interviews with community leaders. Our team will assess feasibility, accessibility, and commercial potential of the adapted intervention, with the goal of targeting key parenting mechanisms (parenting practices and cultural socialization) to improve youth mental health and inform broad public health efforts to reduce mental health disparities.